Administrative Core

Abstract LSUHSC CARC Administrative Core
The purpose of the Louisiana State University Health Sciences Center (LSUHSC) New Orleans Comprehensive
Alcohol-HIV/AIDS Research Center (CARC) is to conduct cutting-edge translational research on the causes and
biomedical consequences of alcohol use and abuse and their impact on biomedical and psychosocial comorbid
conditions of persons living with HIV/AIDS. The goal of the CARC is to generate evidence-based knowledge on
the interaction of alcohol and HIV disease that will inform health care providers and will lead to effective primary
care-based interventions to decrease risky alcohol use, HIV transmission and improve health outcomes. The
Administrative Core of the CARC will provide oversight and the organizational framework for the direction,
management, and coordination of all activities. Specifically, the Administrative Core will (1) monitor the
performance and productivity of the individual research components and cores; (2) manage the budget and fiscal
activities of the CARC; (3) supervise the CARC personnel; (4) provide data collection, management, and analysis
support, and (5) provide oversight for the educational, enrichment and dissemination functions of the CARC. In
essence, the Administrative Core is responsible for centralizing, coordinating, and integrating research and
administrative components of the CARC. Dr. Molina, Principal Investigator and Director, and Dr. Nelson, Co-
Director, will direct all CARC-related activities in consultation with the Intramural Center Committee. The
Administrative Core will facilitate logistics for synergistic, productive, and seamless interaction among the
participants to substantially enhance the success of CARC activities. The Administrative Core will foster formal
and informal exchanges among members of the CARC and the intra- and extramural scientific community to
allow for peer-review, idea cross-fertilization, and development of new collaborative projects focused on the
biomedical health consequences of alcohol abuse. The Administrative Core is a mature, integrated component
of our CARC with a successful record in supervising, promoting, and developing comprehensive, thematically
focused research programs that are both productive and cost-effective in an area of great clinical relevance.